EOI:: IMPLEMENTING THE PRESIDENT'S DEPARTMENT OF GOVERNMENT EFFICIENCY COST EFFICIENCY INITIATIVE (MARCH 19, 2025)::EOI BILATERAL MODIFICATION TO DESCOPE WORK FOR NATIONAL FERRET RESOURCE AND RESEARC

The National Ferret Lung Research & Resource Center (NFLRRC) does not have an abstract. The overall objectives and proposed areas of research during the funding period will be to facilitate the utilization of ferret models for lung disease by generating genetically modified animals, biological specimens, reagents, easily accessible omics data, and by expanding the genetic toolbox for ferret-based research on lung biology.